Training Program in Integrative Developmental Process

Project Summary (Abstract)
This is a basic science training grant focused on an integrative understanding of post-natal
human behavioral development. The rationale for the focus on integrative training is that
effective translation requires more than merely rapid movement of single-variable basic science
findings to efficacy studies but a different basic science, one that embraces complex causal
pathways of development, and considers processes at nested time scales and multiple levels of
analysis. The training program focuses on behavioral development (and relations to brain
development) because advancing research shows that post-natal behavior and the experiences
generated by that behavior modulates both structural and functional connectivity in the brain,
tunes specialized neural systems and influences gene expression, with atypical patterns of early
behavior and experiences determining the quality and opportunities of whole lifetimes. The
trainees are 5 predoctoral candidates in psychology and in two joint PhD programs in
psychology and neuroscience and in psychology and cognitive science and 3 post-doctoral
fellows from various fields interested in developmental process. The training program for pre-
doctoral trainees is 5 years (with 2 years supported by the training grant and 3 years by the
department of Psychological and Brain sciences); the training program for post-doctoral trainees
is typically 2 years. All trainees are required to submit at least one grant (foundation, F31, F32,
or NSF) while affiliated with the program. The training program emphasizes the use of cross-
levels methods to study the same problem, basic science that can link to translation, the
collection and analysis of large data sets, open data and data sharing, and the ethical conduct
of research.

Public health relevance
Project Narrative The Integrative Training Program in Developmental Process trains researchers in typical and atypical patterns of behavioral and brain development, with the goal of understanding how early achievements in that process (for example, motor development, language learning, sleep patterns) set the stage for and support later achievements (for example, in sustained attention, behavioral control, school success). By understanding how development builds on itself and the potential multiple pathways to healthy developmental outcomes, we may foster healthy outcomes in children facing challenges from poverty, from sensory-motor disabilities, and from developmental disorders such as autism.